Phase 1 study of a SARS-CoV-2 vaccine adjuvanted via controlled biodistribution of mRNA encoding spike protein and IL-12p70

Project Summary
mRNA-lipid nanoparticle (LNP)-based vaccines are an exciting platform that made advances in
combating the pandemic viruses. However, currently licensed mRNA-LNP vaccines approaches
are limited in their ability to induce long lived antibody durability, degree of protection varies by
age, and levels of cell mediated immunity (CMI) are suboptimal. mRNA vaccine self-adjuvantation
is lower in aged individuals, with impaired immune activation upon exposure, inducing insufficient
immunity with consequential impaired protection. To try to advance solutions, our published and
unpublished work focus on two major novel mRNA vaccine innovations. One is a multi-organ
protection (MOP) mRNA sequence homologous to tissue-specific micro-RNAs and enable tissue-
specific mRNA translation, constraining expression to the site of injection. Secondly, a biological
mRNA-encoded molecular adjuvant precisely guides immunity through inducing the potent and
Th1-polarizing analyte, IL-12p70. Based on promising SARS-CoV-2 spike-trimer specific humoral
and CMI, in young and aged murine models, and protection from viral challenge in non-human
primates (NHPs), the goal of this U01 IICT application is to evaluate a mRNA encoding
molecular adjuvant, delivered alongside MOP technology, in the context of a SARS-CoV-2
vaccine. Spike-MOP (CTx892) and IL-12-MOP (CTx672) are first-in-human evaluations, so to
assess safety and tolerability, we would first perform dose escalations for CTx892 (stage 1A) and
CTx 672 (stage 1B). Based on tolerability, doses less than maximal tolerated CTx892 are chosen
to expand sample size for subsequent immunogenicity and mechanism studies. In stage 2, two
different doses of CTx 892 will be paired with an escalating CTx672 (IL-12-MOP, e.g., 0.1, 1 µg)
dose to assess adjuvanticity along with local and systemic safety and tolerability. Additionally,
humoral immunity will be quantified with Spike-specific total IgG (titer and pre-immunization fold-
change), IgG1 and IgG3 (Th1 markers), and IgG4 (Th2 marker), with surrogate virus, pseudo-
virus, and true viral neutralization. Cellular immunity will include innate assessment in the days
after, and adaptive CD4, CD8, and B cell immunity in the weeks, post-immunization. Further
readouts include dried blood spots in the hours post-injection to assess proteomic kinetics. In
Stage 3, biopsies of lymph node at ~14 days post-immunization and bone marrow at 6 months
post-immunization will enable in-depth immunophenotyping and quantification of long-lived
plasma cell (LLPC) responses. Durability of humoral and cellular immunity will be probed with a
6-month follow-up sampling of peripheral blood, IL-12-sustained humoral and cellular immunity.

Public health relevance
PROJECT NARRATIVE mRNA-lipid nanoparticle-based vaccines have brought major advances in combating respiratory infectious diseases, but limitations such as overt higher rates of reactogenicity and lack of durability of responses, especially in older adults, and questions around mechanism of action, remain. This U01 application evaluates an mRNA encoding a molecular adjuvant interleukin (IL)-12 delivered by controlled biodistribution via a novel gene silencing platform called MOP (multi-organ protection), along with an mRNA Spike antigen also delivered with a MOP sequence in the context of a SARS-CoV-2 vaccine. This is a randomized phase 1 clinical trial testing safety and tolerability of dose escalation of the spike-MOP antigen and IL-12 MOP adjuvantation system.